Development of platform technology to measure kinetics and equilibrium concentration of sickle hemoglobin polymerization in single RBCs for drug potency assessment and patient risk stratification

Sickle cell disease is caused by the pathologic polymerization of variant sickle hemoglobin (HbS) when
deoxygenated. Polymerization of HbS inside red blood cells (RBCs) immediately compromises RBC morphology
and blood flow properties, and it also triggers exacerbation of inflammation and cellular adhesion to
endothelium, ultimately leading to ischemia, vaso-occlusion, stroke, tissue damage, and acute and chronic
organ dysfunction. The only approved drugs are far from curative, with incompletely understood mechanisms,
and the quality of life for most sickle cell patients remains poor with life expectancy in the US reduced by more
than 30 years. The prospects for improvement in sickle cell treatments have increased significantly in recent
years with scientific and technological developments making multiple promising treatment approaches more
realistic including gene therapy, gene editing, fetal hemoglobin induction, and hemoglobin (Hb) affinity
modulation.
These new treatment approaches share the same basic mechanism of action: reduce the amount of Hb
polymer in RBCs at physiologic oxygen tensions. Perfect realization of any one of these approaches will cure
the disease, but partial realization is all we can expect, and it is essential for prioritizing and optimizing
treatment development that we be able to measure the intracellular Hb polymer concentration, the kinetics
of Hb polymerization, and the reduction in Hb polymer formation achieved by each regimen of each
treatment. The process of intracellular Hb polymer formation has been studied extensively, and theory is well
established with Eaton and Hofrichter's double-nucleation model. Both the kinetics of Hb polymer formation
and its equilibrium levels are sensitive to several factors that complicate measurement including HbS
concentration, concentration of other Hb isoforms, oxygen tension, pH, Hb concentration, temperature,
intracellular flows, and more. We will develop a high-throughput platform to measure the equilibrium and
kinetics of Hb polymerization in single RBCs while controlling and modulating these factors. We will calibrate
the platform by comparing the characteristics of its measurements against existing standard clinical laboratory
instruments and current theory. We will also use it to measure variation across a range of clinical phenotypes
and sensitivity to variation in HbS concentration, Hb concentration, and more. This new platform technology
will enable the development of in vitro markers to optimize treatment discovery, prioritize alternative
strategies, ensure treatment product quality, assess patient response, and optimize individual patient
management. Our study will enable development of quantitative in vitro endpoints for sickle cell disease
derived from measurements of the kinetics and equilibrium of Hb polymerization in individual RBCs.

Public health relevance
There are no effective treatments for sickle cell anemia, a disease affecting millions worldwide that is caused by the pathologic polymerization of sickle hemoglobin inside red blood cells when they become deoxygenated, but there are several very exciting new approaches in development including gene therapy, gene editing with CRISPR, hemoglobin gene regulation, and hemoglobin oxygen afϐinity modulation. All of these treatments work by reducing the amount of hemoglobin polymer that will form at a given oxygen tension, but we currently have no way to measure the amount of polymer in individual RBCs, and we therefore do not know how intense each treatment needs to be for each patient, or which treatment or combination of treatments will be most effective for each patient. This project will validate a platform enabling deϐinition of therapeutic windows for current and experimental treatments as well as their combinations, providing a tool to speed drug development and enable personalization of current and future treatment for sickle cell patients.